Tracking and Evaluation Core

The Tracking and Evaluation (TE) Core of the West Virginia Clinical and Translational Science Institute (WVCTSI) uses collaborative capacity building evaluation and accountability frameworks to assist all cores in their evaluation and data-based decision-making processes, empowering core personnel to recognize and address challenges to productivity and desired outcomes. No evaluation entity with the infrastructure and resources to accomplish programmatic evaluation at this scale existed here prior to WVCTSI funding. During Years 1-10, TE Core established robust systems and processes to provide leadership and personnel with objective performance data to assess progress toward Aim achievement. In this second renewal application, TE proposes innovative new initiatives to enhance the WVCTSI’s capacity to evaluate its progress, maximizing accountability and programmatic improvement. These efforts will be accomplished through the following specific aims: 1) Leverage creative existing platforms to further increase capacity among WVCTSI personnel outside of TE Core to rapidly translate evaluation findings to practice through innovative evaluation data science resources and regular evaluation data use training workshops; 2) Drive quality improvements in WVCTSI services and support through investigator-centric programmatic evaluation that enables clinical/translational (C/T) investigator productivity; and 3) Develop and a disseminate portable toolkit of programmatic evaluation models that drive continuous quality improvement and demonstrate statewide impact on rural health and healthcare. For aim 1, TE Core will increase the capacity of WVCTSI personnel to rapidly translate evaluation findings to practice by identifying recurring evaluation data needs and developing user-friendly web-based data science resources that provide data visualizations in near real-time and also providing regular training in utilization of these resources and data-based evaluative thinking. For aim 2, TE Core will develop a central database logging every instance of service delivery to investigators and associating that data with all other investigator data points. Analyses of these data will guide qualitative work with investigators to identify and remove challenges impacting their productivity through improved services and service delivery by all cores. For aim 3, TE Core will develop and package for portability two evaluation data models that focus on a) PBRN connectivity and impact on rural health and healthcare, and b) hub-and-spoke knowledge transmission to support rural health care providers and positively impact their patients. Three key innovations involve: a) sophisticated data science tools and evaluation capacity building to rapidly translate evaluation findings to practice, b) driving quality improvement through investigator- centric programmatic evaluation, and c) disseminating a portable toolkit for programmatic evaluation in rural health and healthcare settings. Integrating these key innovations into the programmatic evaluation developed during the current WVCTSI funding cycle will allow rapid transformation of WVCTSI toward sustainability and accomplishment of the overall programmatic goals of this application.